Impact of Amygdala Lateralization on Processing and Modulation of Bladder Pain

PROJECT SUMMARY
Urologic chronic pelvic pain (UCPP) syndromes, commonly diagnosed as interstitial cystitis/bladder pain
syndrome (IC/BPS) or chronic prostatitis/chronic pelvic pain syndrome (CP/CPPS), represent the most
common type of chronic visceral pain disorders. Although dysregulation of peripheral inputs from the viscera
likely account for a number of the symptoms of the diseases, a failure to understand and treat central nervous
system (CNS) changes likely prevents complete recovery for affected patients. The long-term goal of our lab is
to understand the extent to which areas in the brain are responsible for the development and maintenance of
persistent pain and accompanying affective disturbances that exist within urologic conditions. We aim to
discover and develop novel CNS treatment paradigms for this disease to complement approaches directed at
the bladder. Recent evidence has suggested that the central amygdala in the CNS may be an important locus
for the interaction between visceral pain and anxiety, potentially serving as a driver for chronic conditions like
UCPP. By determining the role of the amygdala in animal models of bladder pain, insight will be provided into
the underlying physiology of the human condition. Evidence from human and animal models has shown that
the left and right amygdala may differentially regulate pain. Variances in left and right hemisphere activation
are well described in human language production, visual processing, and complex planning tasks. [Functional
lateralization exists in emotional processing areas of the brain, including the amygdala, across multiple taxa
including birds and mammals where the right brain serves as a reactive center to stress and injury. This
conservation suggests that lateralization of limbic circuits is likely an evolutionarily important phenomenon.]
The idea that dysregulation in lateralization might also play a significant role in disease is a novel concept with
important clinical relevance. UCPP patients show lateralized changes in amygdala gray matter and lateralized
amygdala functional connectivity to other areas in the CNS. The molecular mediators responsible for incoming
information to the left versus right amygdala remain unknown. The objective of this proposal is to determine the
extent of bladder pain lateralization between the left and right central amygdalae and the molecular
mechanisms responsible for this phenomenon. This objective will be met through two distinct but
complementary specific aims. In Aim 1 of this proposal, we will determine the extent of left and right amygdala
activation following stimulation of control or sensitized bladders, while also probing the areas of the brain
through which nociceptive information travels. In Aim 2, we will manipulate specific brainstem projections to the
amygdala to determine which cells are sufficient and necessary for lateralized pain-like output in both control
and sensitized conditions. Overall, this proposal will help determine the extent and mechanisms of amygdala
activation during painful bladder stimulation and the mechanisms by which an overactive amygdala may
contribute to bladder pain as seen in UCPP.

Public health relevance
PROJECT NARRATIVE Patients suffering from urologic chronic pelvic pain (UCPP) syndromes in the form of interstitial cystitis/bladder pain syndrome (IC/BPS) or chronic prostatitis/chronic pelvic pain syndrome (CP/CPPS) have an extremely poor quality of life due, in part, to the cognitive and emotional problems that accompany their pelvic pain and a lack of effective treatments. To learn more about the brain's role in bladder pain in the hopes of finding new therapeutic targets, we focus on the amygdala, a brain area involved in both pain and emotion. These proposed studies will investigate the role of the left versus right amygdala in contributing to and altering bladder pain in mice.